Neurobiological significance of Aqp4 stop codon readthrough

Project Summary/Abstract
Soluble amyloid beta (Aβ) oligomers trigger tau tangle formation, neuronal cell loss, synaptic dysfunction and
cognitive decline seen in Alzheimer's disease (AD). The water channel Aquaporin 4 (Aqp4) is a key component
of the Aβ removal machinery in the brain, as evidenced by ~ 55% reduction in Aβ removal in Aqp4-/- mice.
Specifically, astrocyte endfeet-concentrated Aqp4 is shown to be both required for removing Aβ during sleep
and perturbed in AD, suggesting that restoring Aqp4 to endfeet can improve the outcome of AD. I find that this
endfeet-localized Aqp4 is a stop codon readthrough version of Aqp4. I performed ribosome footprinting (RF),
deep-sequencing of ribosome-protected mRNA fragments, in the mouse brain and detected reads mapping to
the 3' untranslated region of Aqp4, suggesting that ribosomes read past the stop codon and make a C-
terminally extended version of Aqp4 (Aqp4X hereafter). Using an antibody against the readthrough epitope, I
show that Aqp4X is exclusive to the perivascular endfeet, whereas the normal un-extended Aqp4 is confined
elsewhere along the astrocyte membrane. Therefore, the objective of this project is to determine if Aqp4
readthrough enhances Aβ clearance and thus improve AD outcome.
I propose 3 aims to meet this objective. In aim 1, I will determine if Aqp4X has altered efficacy in eliminating
Aβ compared to Aqp4. I will express either Aqp4X or Aqp4 using viral transduction in the hippocampi of
APP/PS1+/- transgenic mice, and use a novel micro-immunoelectrode technology to measure the rate of Aβ
removal from the interstitial fluid in live mice. Next, on the Aqp4-/- nice that I have acquired and Aqp4No_X
mice that I have generated, I will use ELISA to measure their total brain Aβ levels, with or without viral
rescue. I will also examine Aqp4No_X mice for memory and other behavioral deficits. In aim 2, I will identify the
chemical and genetic regulators of Aqp4 readthrough using drug screening and CRISPRi screening,
respectively. Finally, in aim 3, as an independent investigator, I will determine the AD-related
pathophysiological consequences arising from the loss of endfeet Aqp4. To this end, I will examine Aqp4No_X
mice for possible structural and functional defects in the BBB and neuronal-activity dependent gene regulation
in the hippocampus. I will also cross these mice with APP/PS1 mice and test if Aβ burden and behavioral
deficits escalate when an AD mouse loses endfeet Aqp4. Thus, aim 1 will test the necessity and sufficiency of
the two Aqp4 versions in Aβ clearance, aim 2 will allow future studies on potential therapeutics and biological
regulators, and aim 3 will further elucidate the role Aqp4X plays in AD.

Public health relevance
Project Narrative The concentration of amyloid-β (Aβ) is directly linked to its likelihood to aggregate into toxic species in the Alzheimer's disease brain. This proposal will determine the role of Aquaporin-4 (Aqp4), particularly an elongated readthrough version of the protein that occurs naturally, in regulating Aβ clearance via astrocytes. Elucidating the mechanisms that regulate Aβ concentration will provide insight into disease pathogenesis as well as risk of disease, and could suggest a new therapeutic target to enhance Aβ clearance from the brain.